A multimodal approach to develop molecular markers to predict response to immune targeted agents in non-small cell lung cancer

PROJECT SUMMARY/ABSTRACT
This project describes a 5 year training program for a career as a physician-scientist with the long term goal
of establishing a research program within the field of translational thoracic oncology. The applicant is currently
an Instructor of Medicine in the Section of Interventional Pulmonology and Thoracic oncology conducting
research in developing biomarkers for the treatment selection and monitoring of patients with lung cancer. The
research focus of this proposal is to develop molecular markers to better identify the subgroup of patients that
will respond to PD1/PDL1 therapies in order to avoid unnecessary toxicities, reduce costs, and enable more
appropriate therapies to be delivered. This goal will be accomplished in three complementary specific aims. In
Specific Aim 1, mRNA expression analyses will be performed on tumor tissue from advanced lung cancer
patients treated with anti-PD1 therapy to determine the association of specific gene signatures with treatment
response. In Specific Aim 2, a novel approach to acquire fresh tissue samples for immunophenotyping will be
utilized to prospectively determine the ability of deep T cell phenotyping and functional assays to predict
response to anti-PD1/PDL1 therapy using multi-parametric flow cytometry. In Specific Aim 3, a newly
developed technique that enables the quantitative measurement of circulating PDL1 exosomes will be utilized
to determine the association of pretreatment and on-treatment exosomal PDL1 expression levels to predict
clinical outcomes in non-small cell lung cancer patients receiving checkpoint blockade. The training component
of this proposal includes formal coursework, participation in a rich environment of post-doctoral lectures in
thoracic oncology/tumor immunology, acquisition of advanced laboratory techniques (with a focus on
bioinformatics and advanced flow cytometry), and individual mentoring. This project will take place under the
supervision of Dr. Steven Albelda who is the Director of the Thoracic Oncology Laboratory at the University of
Pennsylvania and Co-Director of the Abramson Cancer Center’s Translational Center of Excellence for Lung
Cancer Immunobiology, and Dr. Anil Vachani who is the Director of Clinical Research for the Section of
Interventional Pulmonology and Thoracic Oncology at Penn. Dr. Albelda and Dr. Vachani have mentored over
100 trainees. In addition, an advisory committee of distinguished scientists will provide experimental
assistance, intellectual guidance, and career advice throughout the duration of this award.

Public health relevance
PROJECT NARRATIVE The development of immune checkpoint inhibitors has ushered in a new era of antineoplastic therapy for the treatment of non-small cell lung cancer. However, in the majority of trials, response rates were limited to ~20- 50% of patients. In this application, the candidate outlined a detailed scientific plan to develop molecular markers to better identify the subgroup of patients that will respond to immunotherapeutic agents in order to avoid unnecessary toxicities, reduce costs, and enable a more appropriate therapy to be delivered.